BLRD Research Career Scientist Award Application

AIMS: The goal of this application is to apply for Research Career Scientist (RCS) Award and to support Dr.
Randy Scott Rector’s VA research program. NOMINEE: Dr. Rector is a Research Health Scientist at the Harry
S Truman Memorial VA Hospital since 2011 and a tenured Professor of Medicine in the Departments of Nutrition
and Exercise Physiology and Medicine at the University of Missouri School of Medicine. Dr. Rector has made
significant contributions to the fields of exercise, nutrition, obesity, and steatotic liver diseases. Using technically
and conceptually innovative strategies, he and his research team have been working to identify newer
mechanistic targets in the hopes of developing novel therapeutics for the treatment of nonalcoholic fatty liver
disease/metabolic dysfunction associated steatotic liver disease (NAFLD/MASLD), a significant problem in
Veterans and civilians working for the military. Employing novel mouse models with cell-type specific knockout
and overexpression of target genes and cutting-edge molecular techniques, he and his research team are
investigating to mechanistically answer important questions underlying the molecular mechanisms that drive the
progression of MASLD. In addition to thorough mechanistic interrogation, his lab takes integrative and
translational approaches to better understand the underlying pathophysiology and altered metabolism inflicted
by these conditions. In addition to MASLD, Dr. Rector’s research program at Truman VA directly focuses on
various other chronic diseases that affect our Veterans, including type 2 diabetes. He has published over 170
peer-reviewed publications to date, many in the highest impact journals that include Cell Metabolism, Nature
Communications, Hepatology, Diabetes, and Journal of Hepatology. His laboratory is currently funded by
multiple NIH grants, a VA Merit grant, and industry-sponsored research programs. As part of his VA Research
program, Dr. Rector’s lab also incorporates mentoring of trainees at all levels, from undergraduate research to
training of graduate students, post-doctoral research fellows and physician scientists. IMPACT: NAFLD/MASLD
has become a global epidemic, with progression to nonalcoholic steatohepatitis/metabolic dysfunction
associated steatohepatitis (NASH/MASH; hepatic inflammation) and fibrosis (scarring/injury), increasing the risk
for hepatocellular carcinoma, liver transplantation, and mortality. MASLD affects greater than 30% of the general
US adult population, and disturbingly, prevalence rates are greater in the Veteran population. Unfortunately,
there are no proven pharmacological therapies for the treatment of MASH. Studies led by Dr. Rector’s lab have
provided a molecular understanding of how exercise training improves liver health in MASLD. His lab was also
one of the first to establish that liver mitochondrial dysfunction is intimately linked to advanced stages of liver
disease. In addition, his VA Merit funded work has shown that deletion of hepatocyte-specific endothelial nitric
oxide synthase (eNOS) exacerbates hepatic steatosis and NASH, decreases hepatic mitochondrial function,
increases oxidative stress, and impairs the hepatic mitophagic response. Conversely, overexpressing eNOS
rescues hepatocyte mitochondrial function and attenuates MASH progression. His current VA Merit will address
the critical and mechanistic role of hepatic eNOS in the regulation of hepatic de novo lipogenesis and its role in
the regulation of the inflammatory and fibrogenic programming response in Kupffer cells and hepatic stellate
cells in a preclinical model of MASLD/MASH. These studies will establish the cell type-specific importance of
eNOS and provide further insights into reducing the incidence of MASLD/MASH in our Veteran population. In
summary, Dr. Rector’s research program employs highly innovative molecular and cellular techniques and
utilizes preclinical models and clinical studies to better understand human health and disease that is both novel
and mechanistic and can be applied at the patient level, thus having a direct impact to the health of our Veterans.

Public health relevance
Randy Scott Rector, PhD, has been working at the Harry S Truman Memorial Veterans’ Hospital (HSTVA) since 2004 and transitioned to a Research Health Scientist at the start of his VA-CDA2 in 2011. His research program focuses on identifying novel mechanistic targets for the treatment of nonalcoholic fatty liver disease/metabolic dysfunction associated steatotic liver disease (NAFLD/MASLD), a significant problem in Veterans. His current VA Merit funded research is focused on (1) understanding the role of hepatocyte-specific endothelial nitric oxide synthase (eNOS) in the regulation of hepatic de novo lipogenesis in the development of MASLD and (2) understanding the role of cell-type specific eNOS in the activation of Kupffer cells and hepatic stellate cells in the advancement of MASLD to nonalcoholic steatohepatitis/metabolic dysfunction associated steatohepatitis (NASH/MASH). The overall goal of Dr. Rector’s research program is to utilize preclinical models and perform clinical studies to ultimately improve the health and well-being of our Veteran population.